Multi-Scale Models of Neural Mechanisms Controlling Breathing in Mammals

This research involved the further development and testing of novel neurodynamical models of neurons and networks comprising the respiratory neural control system as studied experimentally in parallel in the rodent brainstem. Data-based models under continuous development included: (1) biophysically realistic cellular-level computational models of brainstem respiratory neurons especially in the inspiratory oscillator (the preBotzinger complex) incorporating current information on cellular architecture and biophysical properties such as ionic conductance mechanisms underlying neuronal activity; and (2) multi-scale models of brainstem respiratory neural networks incorporating available information on network functional and structural architecture. The overall objective of these modeling studies was to gain mechanistic insights into the manner in which cellular- and circuit-level properties are integrated into microcircuits as well as large-scale respiratory networks for the dynamical operation of the mammalian respiratory neural control system. A new model of respiratory central pattern generator (CPG) networks in the rodent brainstem is currently being further developed consisting of interacting excitatory and inhibitory subnetworks distributed in serially arranged brainstem structural compartments, each with distinct functional roles in the generation and control of the respiratory neural activity patterns that evolve during the normal breathing cycle of inspiration followed by expiration. The basic network architecture and cellular properties used in this CPG model are derived from electrophysiological and neuroanatomical reconstruction studies conducted in the rat and mouse brainstem-spinal cord in situ and on subnetworks isolated in living brainstem slice preparations with active circuits in vitro. These models also incorporate regulation of different circuit components by modeled afferent input signals, including rhythmically- and tonically-active inputs from critical neuromodulatory control systems that are known to be involved in the regulation of respiratory activity pattern generation. For analyses of CPG network operation, methods from dynamical systems theory are also applied to identify critical dynamical variables and parameters of circuit operation that underlie respiratory rhythm generation and control the orderly transitions between the functionally distinct phases of inspiratory and expiratory neural activity. In-progress computer simulations with the microcircuit and large-scale network models are able to mimic many features of the single-cell and neuron population activity patterns found experimentally under different in vitro and in situ conditions, including during optogenetic manipulations of circuit activity. A major new hypothesis derived from experimental studies and is being further tested with these models is that the capability to generate oscillatory activity exists within the respiratory CPG at multiple levels of cellular and network organization, forming a robust dynamical system of oscillatory mechanisms. Thus different mechanisms of respiratory rhythm generation can be functionally expressed in a brain state-dependent manner and underlie multiple respiratory motor behaviors, some of which occur under various normal physiological conditions and others of which emerge under pathophysiological conditions such as during severe brain hypoxia (conditions of abnormally low oxygen) and associated failure of synaptic inhibition in respiratory circuits. Simulations with models of different levels of cellular and network complexity are further confirming the plausibility of this concept and have provided insights into the essential cellular and network mechanisms involved. We have also continued implementation of simulation approaches involving cluster computing on large distributed parallel processing systems including the NIH Biowulf high-performance computing cluster that allow real-time simulation of large-scale network models. At the system level, models of the respiratory neural control system were previously developed that couple essential neural circuit dynamics with peripheral respiratory pump mechanics, oxygen and carbon dioxide exchange, blood gas transport, and physiological feedback regulation of central respiratory circuits by signals such as blood/brain levels of oxygen and carbon dioxide. These models have evaluated system-level operation and control in open- and closed-loop model configurations. These models represent the first generation of system-level control models that integrate essential elements of nervous system structural-functional properties and realistic features of the respiratory gas exchange and transport system. All of these models are currently being applied to further explore principles of operation of brainstem respiratory circuits and control of respiratory activity including under various (patho)physiological conditions associated with disturbances of brain and body oxygen/carbon dioxide homeostasis.